FGF IN THE VISUAL SYSTEM

The proposed research will study the role of the fibroblast growth factors (FGFS) on development and regeneration in the visual system. Blindness, whether caused by trauma, diabetic retinopathy, ischemic injury, tumors, infection, or other injury has a dramatic and permanent effect on the quality of an individuals life. The long term goals of this research are to improve knowledge about the factors involved in the development of the retina and its projections to the central nervous system and to develop methods of intervention that will optimize functional recovery of vision after injury. The proposed studies will explore the hypothesis that acidic and basic fibroblast growth factors (aFGF and bFGF), influence development and regeneration in the visual system. The rodent visual system has been chosen for study based on preliminary observations, and the feasibility of experimental manipulation. The FGFs have been isolated from retina and brain and have been shown to have a positive effect on process regeneration in retinal ganglion cells (RGC) in culture. There is also evidence that RGC viability can be increased by experimental manipulations (i,e. attaching a peripheral nerve graft to a severed optic nerve). The experiments in this proposal are specifically designed to: 1) localize aFGF & bFGF, aFGF & bFGF receptors and a &b FGF mRNA in the retina and primary CNS visual areas during development, 2) identify changes in localization and expression of AFGF & BFGF, AFGF & BFGF receptors and AFGF & BFGF MRNA following optic nerve injury, 3) study the effects of exogenous intraocular injection of the FGFs on RGC viability and regeneration following optic nerve injury, 4) study the effect of FGF filled nerve guides attached to severed optic nerve stump on RGC viability and regeneration.